Analyzing the mechanism of exosome mediated DNA Methyltransferase activity during sepsis

Project Summary
This proposal is for a five-year research program for Dr. Jon Wisler, an Assistant Professor in the Division of
Trauma, Critical Care, and Burn Surgery. This proposal aims to study the effects of exosome-mediated
epigenetic regulation that occurs during sepsis, under the mentorship of Dr. John Christman. Dr. Christman is
a highly productive researcher in the fields of monocyte/macrophage biology and epigenetics who has a long
track of mentorship and productivity. The research and career development portions of the proposal focus on
technique expansion and professional development. This includes a refined, logical plan with measurable short
and long-term milestones. Utilizing the extensive experience of his mentorship team, this proposal will train Jon
is cutting-edge technologies including CRISPR-gene editing, live-cell imaging, nanoparticle RNA packaging and
delivery, and exosome biology to greatly improve his mechanistic understanding and investigatory capabilities.
Patients with sepsis exhibit a profound degree of immunosuppression with higher levels of subsequent infectious
complications and increased long-term mortality. Our preliminary data identifies significant increases in DNA
Methyltransferases (DNMT) mRNAs in circulating exosomes of patients with sepsis, and that this DNMT mRNA
is transferred from these exosomes to naïve monocytes. This transfer results in increased epigenetic events
(promoter methylation) and gene silencing. Our intent for this application is to elucidate the mechanisms of
exosome uptake, and target these epigenetic events in an in vivo model of sepsis. We hypothesize prevention
of exosome-mediated DNA methylation allows for maintenance of the host immune response during sepsis. The
overall objective is to identify the mechanistic base that underlies exosome-mediated control of the epigenetic
events that govern sepsis-related immunosuppression, and identify the potential translational value of targeting
DNMT function to treat complications associated with sepsis. Incorporating the training of novel, cutting-edge
techniques will greatly improve the Jon's scientific expertise, and allow for the progression from mentored to
independent surgeon-scientist.
Aim 1: Elucidate the mechanisms that underlie the cellular uptake of exosomes and define the role of
DNMT as an epigenetic messenger that contributes to post-sepsis mediated immunosuppression
Aim 2: Establish the safety and efficacy of targeting exosome-mediated delivery of anti-DNMT to prevent
immunosuppression during sepsis in mouse models

Public health relevance
Project Narrative Each year over 250,000 people die from sepsis and over 1,000,000 are affected. Septic survivors exhibit long- term immunologic dysfunction associated with higher rates of subsequent infections and all-cause mortalities; however, our understanding of the regulation of these responses and their impact on disease is lacking. Utilizing cutting-edge technologies, this proposal will provide an in-depth, in vivo assessment of the systemic epigenetic events that occur during sepsis and how their signal is amplified, which has the potential to provide fundamental insight into disease regulation and novel therapeutics for the treatment of sepsis.